Racial/Ethnic Disparities in Home Health Care for Persons with Alzheimer’s Disease and Related Dementias

Abstract
Alzheimer’s disease and related dementias (ADRD) affect 5.8 million Americans and disproportionately impact
racial/ethnic minorities. Despite their complex health and social needs, the majority of persons with ADRD live
at home and prefer to do so for as long as possible. Consequently, there is a rapid growth in the demand for
home health care (HHC), a leading form of home- and community-based services (HCBS) to support this
vulnerable population. The need for HHC is further intensified among racial/ethnic minorities as research has
shown that they had higher prevalence of ADRD and more severe symptoms of dementia but limited financial
resources for institutional care. At the same time, research from care settings other than HHC has indicated that
minorities such as Blacks and Hispanics are less likely to receiving care from high-quality facilities and are more
likely to have worse outcomes (e.g., rehospitalization and poor function). However, it is unclear whether similar
differences exist among persons with ADRD in the HHC setting. It is also unknown is whether such racial/ethnic
differences are affected by health policies (i.e., home health value-based purchase model, HHVBP) aiming at
improving quality and efficiency of HHC and the availability of HHC resources, nor how much of the differences
can be explained by individual characteristics. We therefore propose a project to elucidate racial/ethnic
disparities in quality of HHC among persons with ADRD. This study has two specific Aims: Aim 1) To examine
admission to high-quality home health agencies among racial/ethnic minority HHC recipients with ADRD (i.e.,
non-Hispanic Blacks, Hispanics, Asians, and Native Americans), compared to their White counterparts. We
hypothesize (1) racial/ethnic minorities with ADRD are less likely to be admitted to high-quality agencies than
their White counterparts, and (2) such differences are smaller in areas with HHVBP model and larger in areas
with less HHC resources; and Aim 2) To determine quality outcomes of racial/ethnic minorities with ADRD during
HHC, comparing to their White counterparts. We hypothesize that racial/ethnic minorities with ADRD experience
poorer outcomes, including higher risk of rehospitalization and less improvement in function during HHC, than
their White counterparts. We will also explore how much of these racial/ethnic differences can be explained by
individual and environmental factors. This study is innovative because it is the first to creatively link multiple
national datasets and use Blinder-Oaxaca method to elucidate racial/ethnic disparities in the quality of HHC
among persons with ADRD. This research is significant as it addresses a growing public health concern
regarding the quality and equity of care for this vulnerable population. Findings from this study will enrich our
knowledge regarding home- and community-based services to racial/ethnic minorities with ADRD. The findings
will inform future efforts aiming at reducing health disparities and improving quality and outcomes of dementia
care in the HHC setting. It has immediate implications for health policy and practice.

Public health relevance
Project Narrative: The proposed research is highly relevant to public health because it addresses an important and timely issue – racial/ethnic disparities in access and outcomes of home health care among persons with Alzheimer’s disease and related dementias (ADRD), and the extent to which such differences can be explained by individual factors and be impacted by government policies. As highlighted in the National Plan to Address Alzheimer’s Disease, achieving equity is crucial in enhancing quality of care for persons with ADRD. Findings from this study will provide empirical evidence to inform clinical practice and policies aiming at improving care and reducing racial/ethnic disparities for persons with ADRD.